Biostatistics

ABSTRACT
The Biostatistics Core provides long-term collaborative support to established programs of research at the
Cancer Center, and short-term consulting services. The work of the Core enhances the scientific objectives of
the Center’s research programs by providing expertise on study design and statistical analysis. The field of
biostatistics is devoted to developing an understanding of the appropriate ways to derive scientific inferences
from quantitative data, and to developing methods for achieving this aim. The staff is highly trained in this field
and were all recruited after extensive national searches. The Core consists of 19 doctoral-level faculty
biostatisticians, assisted by 16 masters-level biostatisticians, 1 bachelor-level biostatistician, and a team of
programming staff and administrative staff. The doctoral-level biostatisticians in the Core have broad, collective
experience in all of the specialized areas of statistical techniques that are pertinent to contemporary cancer
research, including clinical trials methodology, survival analysis, epidemiologic methods, analysis of genomics
data, statistical genetics, methods for diagnostic medicine, evidence-based medicine and psychometric
methods. Cost recovery is achieved primarily through involvement of the Core members and staff as funded
co-investigators on NIH grants. By providing a valid framework for the design, conduct and analysis of scientific
studies, the Core contributes to scientific quality and promotes interdisciplinary research. The broad range of
services and collaborative work provided by the Biostatistics Core has supported the research of 482
investigators in the past year. During the past grant period the work of the Core has contributed to 2,539
publications of researchers from 9 research programs. For example, the Biostatistics Core developed a
method called FACETS to infer copy number alterations from the institution’s IMPACT sequencing assay.
FACETS has quickly become part of the standard toolkit of genomic analysis at MSK.